DREAMS - Enrichment Program

Project Summary/Abstract
Diabetes mellitus is a significant health burden in the U.S. The prevalence of Type 2 Diabetes is growing
rapidly; California leads the nation in incident cases and costs of diabetes. Individuals with low socioeconomic
status, older adults, rural populations, and racial and ethnic minorities are at highest risk. The drivers of these
disparities include a complex combination of interacting factors at the individual, family, community, health
system, societal, and policy levels. Programs and policies that can effectively translate high-quality, evidence-
based diabetes interventions into widespread practice across diverse communities, modes of delivery, and a
range of settings are desperately needed. The Diabetes Research for Equity through Advanced Multilevel
Science Center for Diabetes Translational Research (DREAMS-CDTR) aims to advance health equity
science through the development and translation of: 1) innovations and structural changes to healthcare
delivery systems that substantively reduce health inequalities, and 2) innovative, scalable interventions to alter
the socioenvironmental drivers of the Type 2 Diabetes epidemic and associated disparities.
Focusing on the northern California and its Central Valley region, the DREAMS-CDTR will conduct clinical
research and interventions designed to inform practice and policy change at the health system, community and
policy levels. The DREAMS-CDTR (formerly Health Delivery Systems) brings together translational science
core faculty, half of whom are from groups under-represented in science, who have expertise in diverse, multi-
level areas including: food insecurity, medication adherence, health communication, health IT, social policy,
and cost effectiveness analysis. DREAMS-CDTR will involve four regional academic sites with a range of
public and non-profit health systems that serve large and diverse populations: Kaiser Permanente Northern
California’s Division of Research and the University of California at San Francisco, Merced and Davis.
The DREAMS-CDTR activities include: an Administrative Core, Pilot and Feasibility Program, Enrichment
Program, and three coordinated research cores - Health Equity & Action Translational (HEAT) core, Methods
and Data Integration (MDI) translational core, and National Diabetes Policy Research Resource core. The
HEAT Core will employ a multi-level systems approach to designing rigorous action-oriented observational and
interventional research. The MDI Core will systematically prepare and support DREAMS-CDTR members in
harnessing novel advances in methods and data to achieve greater health equity in Type 2 Diabetes. Lastly,
the novel National Diabetes Policy Research Resource Core (National DPR Core) will extend the reach of the
DREAMS-CDTR expertise and resources beyond the primary institutions in five key areas of expertise: (1)
natural experiments research,(2) health economics, including comparative effectiveness and cost-effectiveness
analysis; (3) simulation modeling, (4) machine learning, and (5) communicating science to policy-making
institutions, community partners, health departments, and human service organizations.